Prelimbic somatostatin peptide signaling in binge ethanol consumption

ABSTRACT
Alcohol use is a major risk factor for Alzheimer’s Disease and Related Dementias (ADRD), but the biological
mechanisms by which alcohol consumption leads to this increased risk are poorly understood. The aims of the
parent award are to understand binge drinking-induced reductions in somatostatin peptide signaling within the
prelimbic cortex – a key nexus for executive functioning, memory, and other cognitive-related behavior. In this
supplement, we will extend this work to understand whether this alcohol-induced reduction in somatostatin is a
mechanism of increase amyloid beta plaques. We will build upon existing literature suggesting that somatostatin
is a key regulator of the enzyme neprilysin, known to prevent the initial formation of plaques, and that binge
drinking breaks down this preventative pathway. We will explore 1) how binge drinking leads to reductions in
SST peptide expression and transmission, and how this relates to reductions in neprilysin and amyloid beta
buildup; 2) the ability for somatostatin agonists to reduce both cognitive decline and alcohol-induced cognitive
decline, including in memory and exploration-related tasks. By complementing experiments in the parent award,
we will collect new data on this innovative hypothesis for alcohol-induced ADRD risk. Public Health
Statement: This administrative supplement will expand our understanding of the basic mechanisms by which
binge alcohol drinking contributes to the cognitive decline seen in Alzheimer’s Disease and Related Dementias.
A better mechanistic understanding of this mediator of decline is necessary for targeting both treatments and
preventative efforts.

Public health relevance
PROJECT NARRATIVE Despite the relationship between binge drinking and cognitive decline, few treatment options exist - in part driven by the lack of mechanistic understanding of both alcohol-related effects on the brain, and how these changes overlap with the development of Alzheimer’s disease and related dementias. This administrative supplement will extend our work on the involvement of a specific population of neurons and peptides in the prelimbic cortex in binge drinking behavior by further exploring alcohol-peptide interactions that suppress enzymes involved in amyloid-β degradation. This work will provide key insights into the neurobiological underpinnings of the interaction between binge drinking and cognitive decline - and support efforts to develop treatments for reducing alcohol use disorder (AUD)-induced agitations of healthy aging.